Deep Learning for Single-Cell Genetics

ABSTRACT
The dissection of genetic, molecular, and cellular heterogeneity in human complex diseases is imperative for
understanding disease pathogenesis and advancing the therapeutics. Recent progresses in genetics and
single-cell genomics have generated massive datasets, such as those from the UK Biobank and the Human
Cell Atlas, providing great opportunities to investigate the genetic underpinnings of complex diseases and the
cellular diversity across human tissues. However, existing computational and statistical methods are
compartmentalized for genetic or single-cell data analysis, lacking a seamless integration needed to link
genetic variants to specific cellular processes. This limitation impedes the differentiation of disease-causing
genetic factors from confounding elements, resulting in an incomplete grasp of cellular and molecular disease
mechanisms. In response, we propose a pioneering research field, “single-cell genetics,” aimed at
systematically integrating cutting-edge single-cell genomic data into genetic analysis. Our goal is to develop a
suite of deep learning methods, serving as the methodological foundation for single-cell genetics, to address
fundamental challenges in disease genetics, including variant interpretation, gene discovery, cell prioritization,
and disease prediction. This initiative not only leverages recent breakthroughs in artificial intelligence and
single-cell genomics to elevate genetic discoveries, but also explores a new direction that extends the
boundaries of genetics towards single-cell resolution. Specifically, we will first develop a novel sequence-based
deep learning model to predict gene expression from DNA sequences. This model, trained on extensive
single-cell and individual-level data, allows for a comprehensive characterization of cell-specific transcriptional
regulation and accurate prediction of variant impact across individuals. Second, we will design a unified deep
learning framework that connects single-cell reference data with summary statistics from genetic association
studies. Accommodating both common and rare variants, along with various single-cell profiling data, this
versatile framework enables the prioritization of disease-critical cells and identification of cell-specific risk
variants and genes. Finally, we will develop novel deep learning-based genetic risk scores that integrate
single-cell-resolved annotations with common or rare variants for individualized disease prediction. This
approach shifts from the conventional statistical, linear principle of polygenic risk scores to a biologically
informed, nonlinear framework, offering enhanced model interpretability and disease prediction. Overall, this
proposal seeks to establish a next-generation paradigm for genetic analysis, provide foundational deep
learning algorithms with applications in comprehending the genetic, molecular, and cellular underpinnings of
complex diseases, and generate new actionable biological hypotheses for disease mechanisms and
therapeutic targets. The resulting software and data resources will be made publicly available through
open-access platforms, contributing valuable assets to the broader scientific community.

Public health relevance
PROJECT NARRATIVE This project pioneers the field of single-cell genetics, bridging genetics and single-cell genomics to decipher the genetic, molecular, and cellular basis of human complex diseases. Through the development of cutting-edge deep learning algorithms, it seeks to establish a foundational methodology with broad applications in disease genetics, spanning variant interpretation, gene discovery, cell prioritization, and disease prediction. The successful completion of this project promises to significantly enhance our understanding and capabilities in addressing complex diseases, ultimately improving human health.